Epigenetic regulations of DNA and histone methylation and deMethylation: Structures and Mechanisms

Summary/Abstract
Rapid advancements in identifying readers, writers, and erasers of epigenetic modifications, particularly in
DNA and histone marks, have sparked increased interest in understanding their influence on protein-DNA
interactions. This interest is driven not only by the essential role of these interactions in gene expression
control but also by the emerging potential of DNA-binding transcription factors (TFs) as druggable targets. In
mammals, DNA 5-methylcytosine (5mC) serves as a major epigenetic signal that regulates chromatin structure
and, consequently, gene expression. Our research has revealed that many DNA-binding TFs are responsive to
the CpG methylation status of their binding sites, including unmodified, 5mC, and successively oxidized forms
(5-hydroxymethylC, 5-formylC, and 5-carboxyC). Despite these insights, significant challenges persist in
unraveling how specific chromatin regions are targeted for methylation, oxidation, and demethylation,
understanding the impact of CpG methylation on genome stability, and elucidating the coordinated effects of
DNA and histone modifications on TF binding at DNA-regulatory elements to regulate the expression of
specific genes.

Public health relevance
Project Narrative During development, mammalian cells undergo dynamic changes in DNA methylation marks, transitioning from fetus to adult. These modifications, involving the conversion of methylated cytosine into oxidative marks, are hypothesized to be recognized by specific transcription factors crucial for maintaining epigenetic memory. A comprehensive understanding of these processes through detailed biochemical and structural analyses is essential for shedding light on this complex issue.